Refinement of a Digital Monitoring System to Reduce Risk of Hospital Acquired Pressure Injuries

Project Summary/Abstract
The goal of the proposed SBIR project is to develop, implement, and demonstrate the feasibility of a Digital
Pressure Ulcer Monitoring (DPM) system to reduce the risk of Hospital-Acquired Pressure Ulcers (HAPIs).
HAPIs are a common, costly, and serious problem for public health. Ocuvera’s DPIM system will use data from
three-dimensional video processing and custom algorithms to detect and predict risky patient behaviors as well
as to automate nurse record keeping related to HAPIs. During Phase I, algorithms were refined, tested, and
customized to different subtle patient behaviors that are related to risk of HAPI development. We implemented
these algorithms in a proof-of-concept DPIM system that was evaluated in a clinical environment. During
Phase II, we will refine existing algorithms to address clinical feedback gathered during Phase I, collect
additional data, and conduct field testing at partner clinical sites. The product resulting from this research will
prevent injury and promote health in acute care and rehabilitation settings, thus improving health outcomes
and quality of life for patients and healthcare workers.

Public health relevance
The Ocuvera digital pressure injury monitoring system is designed to assist in management of Hospital Acquired Pressure Injuries (HAPIs) by providing an additional tool for nurses to have their patients automatically observed. During Phase I, the Ocuvera team developed algorithms to monitor patient postural changes associated with HAPIs and conducted preliminary testing. The proposed Phase II project seeks to further refine development of the system and to test a prototype in more varied patient populations, with the goal of creating a tool to reduce HAPI risk and improve outcomes for patients and healthcare facilities.